Engineering High-Fidelity Human Cochlear Organoids

PROJECT SUMMARY
Loss of sensory hair cells and/or innervating neurons in the cochlea causes irreversible hearing loss in
humans. However, progress on research for realizing biological restoration of hearing has been hampered due
to the paucity of human cochlear tissues. My laboratory recently developed a novel organoid system to
generate inner ear sensory epithelia containing functional sensory hair cells from aggregates of human
pluripotent stem cells in 3D culture. While these first-generation organoids are a valuable tool for studying
human inner ear development, they only generate hair cells with structural and functional properties of native
vestibular hair cells and fail to produce any cochlear cell types. Another limitation with our original system is the
lack of central nervous system components. To overcome these limitations, we aim at developing a next-
generation human microphysiological system that more faithfully recapitulates development of the auditory
periphery and brainstem. In Aim 1, we will carry out genetic programming and a small-scale CRISPR screen to
increase the number of outer hair cells arising in cochlear organoids. The identity of derived hair cells will be
validated by single-cell electrophysiology, electron microscopy and single-cell RNA-sequencing. Additionally,
maturation of derived hair cells will be promoted by thyroid hormone treatments. In Aim 2, we will establish
novel human cochlear-hindbrain assembloids and assess afferent neural circuit development in these
assembloids. In Aim 3, we will develop dynamic/tunable hydrogels and test if introducing a spatial gradient of
stiffness in the microenvironment during organoid formation can affect tissue patterning or cellular
differentiation. Spatial gradients of signaling molecules will be also introduced in hydrogels to test if the dorso-
ventral axis formation can be recapitulated during organoid differentiation. The outcome of this study will
provide a paradigm-changing approach for studying normal and pathological development of cochlear hair
cells and their ascending neural circuits.

Public health relevance
PROJECT NARRATIVE Sound-sensing cells in the human inner ear are vulnerable to damage, resulting in permanent hearing loss. There is currently no treatment option to biologically cure profound hearing loss. This study will establish a novel human in vitro platform with which to study the cause/progression of hearing loss and identify/test promising therapeutic approaches to treat hearing loss.